Epigenomics Workshop for Graduate Students

PROJECT SUMMARY
The field of epigenomics is expanding rapidly, driven in large part by new and evolving technology,
methods, and techniques. It also is becoming increasingly interdisciplinary. The rapid advance of
omics technologies into multiple specialty disciplines has created a new series of challenges for
scientists-in-training, primarily because every technique or software program has its own
assumptions, biases, caveats, and relative merits that directly affect (or limit) the conclusions that
can be drawn from such studies. The objectives of the “Epigenomics Workshop for Graduate
Students” are to provide a broad overview of cutting-edge omics technologies, epigenetics
research questions, and an intimate, problem-based learning environment with research experts
so that participants will understand innovative methods for studying epigenomics, apply these
tools to interdisciplinary research questions in the field, and build meaningful connections with
research leaders and other graduate students in the broader epigenomics field. The one-week
workshop at Van Andel Research Institute will be led by epigenomics research leaders and have
space for 15 graduate students per year. It will increase diversity and enhance the training of 75
biomedical researchers to meet the growing demand for highly skilled epigenomics researchers
with broad foundations, enabling them to tackle innovative, interdisciplinary questions and bring
this knowledge back to their current labs. We also will build a community of early career
epigenomics scientists who are connected beyond their subfields to the broader epigenomics
field.

Public health relevance
PROJECT NARRATIVE Epigenomics is the study of reversible genomic modification and organization, and how these processes control gene expression, variation and phenotypic programming. These modifications impact human health and disease, and research to understand their impact is necessarily a highly interdisciplinary endeavor. This workshop will enhance training of the biomedical research workforce by providing early stage researchers with a broad, integrated understanding of epigenomic technologies and software, and enabling them to address innovative, interdisciplinary questions.